New Therapeutics for Treating Cocaine Addiction Targeting D1-D2 Heteromers

PROJECT SUMMARY/ABSTRACT Cocaine abuse has reached epidemic levels in North America. By 2018, over 5.5 million Americans over the age of 12 had used cocaine within the past year, and almost 1 million meet DSM-IV criteria for addiction. Overdose related deaths have more than doubled from 2007 to 2018, reaching almost 14,000. Currently, there are no FDA approved medications available for treating cocaine addiction. About 24% of those seeking treatment will relapse within a year following treatment. Relapse rates in abstinent patients are high, because the currently available treatment regimens do not adequately address addiction. Chronic cocaine abuse leads to lasting adaptations in the limbic, motivational, and executive areas of the brain. Glutamate homeostasis is altered, and results in changes in receptor expression in the ventral tegmental area (VTA) and changes in signaling into the VTA and prefrontal cortex (PFC); relapse is associated with enhanced glutamate transmission from the PFC and amygdala into the VTA. These lasting changes result from upregulation of short-lived CREB and sustained elevation and accumulation of ΔFosB, especially in the nucleus accumbens. By reducing the expression of ΔFosB in the nucleus accumbens, the lasting neurological changes associated with the addictive state can be mitigated, and cocaine addiction can be successfully treated. To date, the search for a medication that can effect this change has not been successful. One potential unexplored avenue involves targeting D1-D2 heterodimers, which are largely expressed selectively in the medium spiny neurons in the nucleus accumbens shell. Mounting evidence indicates that selectively agonizing the D1-D2 heterodimers can block upregulation of CREB and the resulting overexpression of ΔFosB in the nucleus accumbens. Thus, this approach represents a novel route for treating cocaine abuse and relapse, and holds high potential for treating cocaine abusers and keeping cocaine- free abusers abstinent. In order to fulfill this goal, we will first focus on the synthesis of novel heterobivalent molecules which target the D1-D2 heterodimer. Second, we will evaluate the ligands for affinity, selectivity, and agonist activity at the D1-D2 heteromer complex. The goal of this project is to develop a selective D1-D2 heterodimer agonist as a novel potential therapy for cocaine addiction.

Public health relevance
PROJECT NARRATIVE Cocaine has reached epidemic levels in North America: by 2018, over 5.5 million Americans over the age of 12 had used cocaine within the past year; almost 1 million meet criteria for addiction; by 2018, almost 14,000 have died from overdose; of those who seek treatment, 24% relapse within year. Chronic cocaine abuse leads to lasting adaptations in the limbic, motivational, and executive areas of the brain, result from upregulation of short-lived CREB and sustained elevation and accumulation of DFosB, especially in the nucleus accumbens; to date, the search for a medication that can treat these changes has not been successful. We propose to develop medications that will directly target these proteins: the goal of this project is to develop a selective D1- D2 heterodimer agonist as an effective therapy for cocaine addiction.